Epigenetic regulation of autophagy and stemness of MSCs in skeletal aging

Project Summary/Abstract
The long-term objectives of this application are to understand epigenetic mechanisms that control long and
orofacial bone aging and to explore whether targeting epigenetic factors could help to prevent age-associated
bone loss. The age-related bone loss is a critical risk factor for osteoporosis that affects millions of patients
worldwide. It also represents a significant challenge for functional reconstruction or regeneration of dental, oral,
and craniofacial tissues such as dental implants for replacing missing teeth in elderly people. Bone marrow
mesenchymal stromal/stem cells (MSCs) are believed to be the common progenitors for both osteoblasts and
adipocytes in bone marrow, but commitments to these two lineages are mutually exclusive. Aging reduces the
bone marrow MSC number and its self-renewal, and favors their differentiation into adipocytes at the expense
of osteoblasts, resulting in bone loss. Using siRNA screening, we discover that the histone demethylase
KDM4B plays a critical role in osteogenic differentiation of MSCs by erasing trimethylated histone H3 at lysine
9 (H3K9me3). The expression of Kdm4b is significantly downregulated in MSCs isolated from aging mice
compared to young mice. Very recently, we demonstrate that the knockout of KDM4B in MSCs in vivo
exacerbated skeletal aging and osteoporosis by reducing bone formation and increasing marrow adiposity via
increasing H3K9me3. To explore whether the induction or activation of KDM4B prevent skeletal aging in vivo,
we generated knockin mice overexpressing Kdm4b. Very excitingly, we find that the overexpression of Kdm4b
significantly attenuates mouse skeletal aging. Unexpectedly, our RNA-seq analysis reveals that the induction
of KDM4B in aged MSCs epigenetically promotes autophagy and inhibits the senescence gene signature in
addition to the modulation of cell fate and stemness. Growing evidence shows that autophagy helps to maintain
the self-renewal of adult stem cells by preventing their senescence. The impaired autophagy attenuates MSC
stemness and promotes MSC senescence and exhaustion in skeletal aging. While key molecules or signaling
pathways associated with autophagy have been elucidated, how autophagy in skeletal aging is epigenetically
regulated is poorly understood. Based on our exciting novel discoveries, we hypothesize that KDM4B
epigenetically regulates autophagy, senescence and self-renewal of MSCs in skeletal aging. We propose to
examine whether the induction or activation of KDM4B in aging mice rejuvenates MSCs and prevents skeletal
aging by promoting autophagy and stemness using genetic and small molecule approaches. New findings from
our studies will have important implications in developing innovative therapeutic strategies for preventing
skeletal aging and osteoporosis as well as promoting MSC-mediated bone regeneration.

Public health relevance
Public Health Relevance Statement Our application is to examine how the epigenetic factor regulates self-renewal and removal of unnecessary or dysfunctional components of adult stem cells in skeletal aging. The discoveries from this study will have important implications in developing novel strategies for preventing aging-related bone loss and promoting stem cell- mediated craniofacial bone regeneration.